Studying the Genetics of Aging, Behavioral, and Social Phenotypes in Diverse Populations-Supplement

PROJECT SUMMARY/ABSTRACT
This proposal requests a Research Supplement to Promote Re-Entry into Health-Related Research Careers
(NOT-OD-23-170) to support Dr. Jeffrey Swigert as he resumes his research career following a formal hiatus
due to family caregiving responsibilities. This supplement will provide structured mentorship and research
training to reintegrate Dr. Swigert into health-related genomics research while advancing the objectives of the
parent R01 grant (R01 AG081518). The parent project focuses on developing novel statistical genetics tools to
improve genetic research on aging, behavioral, and social phenotypes in heterogeneous populations. One such
tool, Genetic-Relatedness-Matched Association (GRMA) studies, enables more powerful genome-wide
association studies (GWAS) by leveraging distant relatives to enhance statistical precision while mitigating
biases associated with traditional ancestry-based methods.
This supplement will address a key limitation of GRMA by developing an improved method for estimating
linkage disequilibrium (LD) structures in genetically heterogeneous populations. Standard LD matrices and
scores, which are essential for downstream applications such as heritability estimation, genetic correlation, and
polygenic index (PGI) construction, are currently incompatible with GRMA summary statistics. Dr. Swigert will
formalize the theoretical framework for GRMA-based LD estimation, develop software tools to generate
appropriate LD resources, and validate these tools using large-scale biobank data such as UK Biobank and All
of Us. The results will be made publicly available, significantly expanding GRMA’s applicability and enabling
broader adoption by the research community.
To support Dr. Swigert’s long-term research independence, this supplement also includes a comprehensive
re-entry plan with targeted mentorship, participation in key genomics and social science conferences,
structured training in statistical genetics methodologies, and hands-on experience in grant writing, software
development, and research leadership. By the conclusion of the supplement period, Dr. Swigert will be well-
positioned to secure independent funding and contribute meaningfully to genomics research on health and
aging. This proposal directly aligns with the goals of the NOSI by facilitating the re-entry of a highly qualified
researcher into biomedical research while enhancing the impact of the parent grant’s innovations in statistical
genetics.

Public health relevance
PROJECT NARRATIVE This research aims to develop better tools for studying how genetics influence aging, behavior, and health. By improving methods for analyzing genetic data from a wider population, this project will help make genetic research more accurate and inclusive. The findings could lead to better understanding of health risks and more effective strategies for promoting healthy aging.